Coxiella burnetii Subversion of Host Nrf2 Antioxidant Signaling- Resubmission

Coxiella burnetii is the intracellular bacterial agent of human Q fever, an acute flu-like illness that can present as potentially fatal chronic endocarditis. Mechanisms used by C. burnetii to parasitize human macrophages remain a mystery. However, through the use of other cell models, studies have demonstrated that C. burnetii regulates numerous host processes, including vesicular trafficking and apoptosis. The current proposal is designed to define mechanisms used by C. burnetii to avoid the oxidative stress response of human alveolar macrophages, which are the pathogen’s target cell in vivo. We found that C. burnetii triggers activation of the cargo receptor p62 and potentially uses this versatile protein to activate the antioxidant transcription factor Nrf2. Aim 1 is designed to define the mechanism by which p62 activates Nrf2. Aim 2 will define the downstream impact of Nrf2 activation on C. burnetii prevention of the oxidative stress response and apoptosis. Throughout the proposal, we will use our primary human alveolar macrophage model of infection to identify disease relevant processes. Collectively, the aims in the current proposal will provide needed insight into the mechanisms used by C. burnetii to parasitize human macrophages, which is a prerequisite for progression of Q fever.

Public health relevance
The bacterial pathogen Coxiella burnetii causes human Q fever, a debilitating acute disease that can present as fatal endocarditis. Central to establishment of infection is growth within alveolar macrophages and prevention of numerous antibacterial insults produced by these cells. Characterization of host pathways, such as Nrf2, manipulated during infection will allow better modeling of the C. burnetii-macrophage dynamic, and this proposal will define a novel mechanism by which the pathogen avoids cellular stress.